Integrated Training in Bone Biology, Biomechanics, and Regeneration (IT3BR)

Project Summary/Abstract
The goal of this new program is to train, educate, and mentor the next generation of biologists, engineers,
physiologists, and biochemists in the intradisciplinary field of musculoskeletal research, with a focus on bone
biology, biomechanics, and regeneration. Multiple diseases along with aging impede the ability of the skeleton
to protect organs, facilitate movement, contribute to mineral homeostasis, and sustain healthy bone marrow.
Degeneration of bone and impaired fracture healing can greatly impact a person’s quality of life. Given the
diverse structure, function, and tissue types that comprise the musculoskeletal system, an integrated and
clinically-informed approach to training is required to keep bone and joints healthy. For example, identifying new
ways to prevent fractures requires an understanding of tissue anatomy, molecular biology, pharmacology,
genetics, vascular biology, material science, biochemistry, and engineering mechanics. Moreover, a translational
training environment is essential to develop musculoskeletal research scientists that will solve the complex scope
of clinical problems affecting the health of the skeleton. Our proposed training program, organized through the
Vanderbilt Center for Bone Biology, will support the education, mentorship, and research of 3 predoctoral
graduate students and 2 post-doctoral fellows for 2 years. Individualized mentorship will be led by faculty across
multiple departments: Biomedical Engineering; Chemical & Biomolecular Engineering; Dermatology; Medicine;
Orthopaedic Surgery; Pediatrics; and Radiology & Radiological Sciences. Mentors also hold primary and
secondary appointments in multiple departments that have graduate programs such as Biochemistry; Cell &
Developmental Biology; Pathology, Microbiology, & Immunology; Molecular Physiology & Biophysics; and
Pharmacology. Our mix of clinical and research faculty will facilitate opportunities to observe physicians seeing
patients in their clinics and hands-on training in bone-specific techniques. Program activities will include seminars
by invited speakers, faculty lectures on the musculoskeletal system, annual career development seminars, work-
in-progress presentations, student-led journal club, and opportunities to participate in our annual musculoskeletal
research symposium. Going beyond the scope of predoctoral student’s didactic coursework in their graduate
program, our program provides a focused curriculum on the basics of bone biology, osteoimmunology, fracture
repair, skeletal development, bone mechanics, imaging, and clinical diagnosis and management of osteoporosis
and osteoarthritis. Professional skills needed for success will be further developed through professional-
association conferences where trainees can present their research to other scientists and network with peers
and potential employers. Structured progress evaluations will further enhance the students’ success in the
program. Encouraging life-long learning and scientific integrity as key to a successful career, the program will
provide an inclusive environment for trainees to investigate ideas with integrity and rigor and to have ample
opportunities for perfecting communication skills, developing resilience, and acquiring leadership tools.

Public health relevance
Project Narrative Maintaining bone health throughout life remains a challenge because of the complex interplay between disease, lifestyle factors, and age-related changes to bone structure and metabolism that increases the likelihood of fragility fractures and decreases the capacity of bone to heal itself. To train predoctoral students and postdoctoral fellows in an integrated research environment, this program supports the type of collaborative research that is needed to fully understand bone structure and function, diseases affecting bone, and bone regeneration. Upon completion, the trainees will be equipped with the knowledge and skill set to develop new strategies and interventions that will keep people mobile, active and healthy throughout every stage of life.